Molecular Biophysics Training Program

Abstract
The Molecular Biophysics Training Program (MBTP) at the Weill Cornell Graduate School (WCGS) is built on a
decades-long history of biophysics research and training at the two institutions comprising WCGS - Weill
Cornell Medicine (WCM) and the Memorial Sloan-Kettering Cancer Center (MSKCC) located across the street
from each other. MBTP will bring together biophysics trainees from two WCGS graduate bi-institutional
programs: the Biochemistry & Structural Biology (BSB) program, part of the umbrella Biochemistry, Cell and
Molecular Biology (BCMB) program and the Physiology, Biophysics and Systems Biology (PBSB) program.
Union of the biophysics trainees in these two programs is a natural fit given that biophysics is inherently
multidisciplinary – bringing together biology, chemistry, physics, computational biology, and mathematics.
MBTP will provide: 1) outstanding learning and mentoring for predoctoral trainees in molecular biophysics; 2)
world-class research opportunities; 3) a diverse and interactive community of students and faculty to foster
scientific exchange and collaboration; 4) strong foundation in performing rigorous and reproducible scientific
research and 5) knowledge of and exposure to various career paths for successful transition into the
biomedical research workforce. The formation of the MBTP program is the latest in a nearly three-decade
maturation of synergistic connections between WCM and MSKCC.

Public health relevance
Project narrative The Molecular Biophysics Training Program is designed to yield a cohort of new PhDs with the skills to apply quantitative approaches rooted in physics to biomedical problems. The program will draw students from bi- institutional graduate programs shared between Weill Cornell Medicine and Sloan Kettering Institute. It will generate scientifically rigorous, thematically organized, socially cohesive and broadly inclusive educational and training environments to prepare students for diverse careers in academic and non-academic fields following timely completion of their doctoral degrees.